Imaging Brain Kappa Opioid Receptors in Early Abstinence Opioid Use Disorder

Abstract
Imaging Brain Kappa Opioid Receptors in Early Abstinence Opioid Use Disorder
The opioid epidemic is one of the worse U.S. public health crises of the past three decades [1]. In response to
this epidemic, the National Institute of Health launched a multi-pronged initiative a goal to develop new
medications for the treatment of Opioid Use Disorder (OUD) [2]. The kappa Opioid Receptor (NOR) system is a
significant driver of continued opioid use, due to its role in negative reinforcement (i.e., the alleviation of negative
affect) often referred to as as the “Dark Side of Addiction.” Yet, understanding the role of NOR in OUD, particularly
in human subjects, remains in its infancy. To address this gap, we conducted the first preliminary human Positron
Emission Tomography (PET) imaging of NOR in people with OUD and saw lower [11C]EKAP binding among
abstinent individuals with OUD vs. healthy controls.
Our first aim is to use [11C]EKAP PET imaging to compare the magnitude and regional pattern of NOR availability
(volume of distribution, VT) of inpatient early abstinent (within 5-10 days of admission) individuals with moderate
to severe OUD (N = 40) as compared to matched outpatient healthy controls (HC; N = 30). Our second aim is
to establish the clinical and transdiagnostic relevance of NOR by testing whether individual differences in NOR
availability: (i) are linked to individual differences in post-inpatient patterns of opioid-use among individuals with
OUD; and (ii) are linked to individual differences in experiences of negative affect and anhedonia across all
participants (OUD and HC individuals). As tertiary aim: we will establish the clinical and transdiagnostic neural
functional correlates of individual differences in NOR by testing whether: (i) individual differences in NOR
availability, among OUD subjects, are linked to individual differences in patterns of functional connectivity within
a previously identified `opioid abstinence network'[3]; and (ii) if we can identify a transdiagnostic functional neural
signature of NOR availability across OUD and HC subjects.
This research will help fill current gaps by providing not only the first human PET data specific for NOR in OUD
but also the largest PET imaging study to date on opioid receptors in this population. It will also be the first to
use multi-modal techniques to explore fMRI correlates of functional connectivity within the OUD group and across
transdiagnostic domains (i.e., negative affect, anhedonia). As such, this proposal, paired with the current
literature supporting NOR medications as one of the 10 most wanted pharmacological agents for rapid
development in response to the Opioid Crisis [4], supports high impact and direct translational application of this
work.

Public health relevance
Project Narrative The kappa opioid receptor (NOR) and the mu opiod receptor (POR) systems are both central to mediating opioid effects in the brain; yet the overwhelming majority of Positron Emission Tomography (PET) imaging work in humans has focused on POR due to the absence of an appropriate PET tracer for NOR. Here, we leverage a recently developed NOR-selective agonist to for the first time (i) compare the magnitude and regional pattern of KOR receptor availability between individuals with opioid use disorder (OUD) and healthy controls; (ii) establish the clinical & transdiagnostic relevance of NOR availability; and (iii) assess the relationship between KOR and network connectivity using functional magnetic resonance imaging (fMRI). The proposed multi-modal and clinical exploration of this system will fill a current clinical research gap of this potential treatment target.